Clinical Core B

Project Summary / Abstract
Core B (Clinical Core) of this NIA U19 Center at the University of Pennsylvania (Penn) Perelman School of
Medicine will be crucial to accomplishing the goals of all Projects and other Cores of this multidisciplinary
research program. The Penn U19 Center focuses on priorities that address Alzheimer's disease (AD) and
related dementias (ADRD) in topic areas of multiple etiology dementias, such as Lewy body (LB) disorders
(LBD), including dementia with Lewy bodies (DLB) and Parkinson's disease (PD) dementia (PDD). Among
ADRD, AD with abundant LB co-pathology is the most common subtype of AD. Hence, AD with LB and Lewy
neurite (LN) alpha-synuclein (aSyn) pathologies (AD+aSyn), PDD and DLB together represent the most
common forms of aging-related dementias. The overall goals of this new Penn ADRD U19 Center are to
elucidate mechanisms of pathological aSyn-mediated progressive neurodegeneration in AD+aSyn versus pure
AD (AD-aSyn), and also compared with LBD, as a function of aging and the heterogeneous accumulations of
aSyn, tau and amyloid β (Aβ) pathologies that influence different and variable clinical manifestations of these
disorders. The aims for Core B are to: (1) recruit, assess and retain research participants with LBD for U19
Projects I-IV; (2) collaborate with Core C for biomarker/biofluid and tissue collection from existing and new
Core B LBD participants, and to assess them longitudinally antemortem for as long as possible to optimize
clinical-pathological correlations; (3) collaborate with Core A to educate the medical community and general
public on LBD and related disorders, and to train the next generation of PD clinical and translational
researchers; and (4) collaborate with Core D to contribute high-quality clinical and biomarker data to the Penn
Integrated NeuroDegenerative Disease Database (INDD) and facilitate sharing of clinical and biomarker data
within and outside of Penn with new and longstanding internal, national and international collaborators.